Implementing sexual orientation and gender identity data collection in the electronic medical record within diverse cancer care settings

Project Summary
A major impediment to research on sexual and gender minority (SGM) cancer prevention, treatment, and
survivorship is the lack of information about sexual orientation and gender identity (SOGI) in medical records
and cancer registries. Given what is known about risk factors for cancer incidence and mortality in SGM
populations, including higher rates of tobacco use, alcohol use and obesity and lower rates of cancer screening
in some groups, this lack of data is an impediment to achieving equitable health outcomes for SGM individuals.
In addition, failure to assess SOGI in clinical settings prevents providers and staff from delivering culturally
competent care. To address these problems, and in accordance with the goals of the NCI Administrative
Supplements for the P30 Cancer Center Support Grants to Enhance Sexual Orientation and Gender Identity
Data Collection, this project will focus on implementation of the National Academies of Science, Engineering
and Medicine (NASEM)-recommended SOGI measures at the Fred Hutchinson Cancer Center (FHCC). The
aims of the project are to: (1) identify patient, provider/staff, administrator and research-stakeholder barriers
and facilitators of SOGI data collection in the cancer care setting; (2) tailor SOGI data collection
implementation plans to address barriers and facilitators and facilitate staff training on interventions to improve
the collection of this data; and, (3) following implementation of SOGI data collection across pilot sites, evaluate
the feasibility, acceptability, appropriateness, and completeness of data in the electronic medical record. This
project is significant in that it focuses on an NIH-defined disparities group that has been underserved in cancer
research conducted to date, and it evaluates the implementation of SOGI data collection not only in the central
hub of an urban Comprehensive Cancer Center but also at an affiliated safety-net hospital with an underserved
cancer care population. It is also innovative in that it will provide a model for a novel implementation of SOGI
data collection with the goal of creating a new standard of care throughout the Center’s catchment area, which
is the entirety of Washington state.

Public health relevance
Project Narrative The lack of data on sexual orientation and gender identity (SOGI) in electronic medical records and in cancer registries is a major impediment to identifying and addressing cancer-related disparities that impact SGM individuals. This project addresses that gap by implementing collection of SOGI data and evaluating the success of the implementation within diverse cancer care settings in the Fred Hutchinson Cancer Center/University of Washington Cancer Consortium.